Preliminary studies of muscarinic M1 receptor availability and cognition in schizophrenia

PROJECT SUMMARY AND ABSTRACT
Background: Converging lines of evidence from postmortem studies provide strong evidence that brain
muscarinic M1 receptor deficit is present in a subset of schizophrenia (SZ) patients. M1 receptors are an
important target for cognitive deficits in SZ. However, until now, it has not been possible to examine the
heterogeneity of SZ with respect to M1 receptor availability in vivo. The development of a novel positron emission
tomography (PET) ligand, [11C]EMO, at Yale PET Center provides a unique opportunity to, for the first time,
examine in vivo brain muscarinic M1 receptor availability in SZ and, concurrently, elucidate the relationship of
M1 receptors to cognitive deficits in SZ. The ligand has high affinity for the M1 receptor, high brain uptake,
appropriate kinetics, excellent test-retest reproducibility (≤ 6% test-retest variability in cortical regions), and
presence of a suitable reference region (i.e., cerebellum) demonstrated in blocking studies. This allows for a
reliable estimation of specific binding to M1 receptors (BPND) using kinetic modeling. The purpose of this
exploratory study is to examine M1 receptor availability in SZ patients and to relate M1 receptor availability to
proximal and distal measures of cognitive performance, namely evoked ɣ oscillations in the EEG and verbal
memory. Furthermore, the relationship between hippocampal [11C]EMO availability (BPND), evoked ɣ oscillations,
verbal memory, and measures of illness severity will be explored.
Hypotheses: SZ subjects will show lower hippocampal M1 receptor availability as measured using [11C]EMO
BPND. Additionally, M1 receptor availability ([11C]EMO BPND) will correlate with verbal memory performance and
EEG indices of encoding (γ power) during a verbal memory task in SZ.
Methods: We will compare M1 receptor availability in SZ and age-, gender-matched healthy controls using
[11C]EMO and the High Resolution Research Tomograph (HRRT), a PET scanner with high sensitivity and
resolution available for human brain imaging. The relationship between hippocampal [11C]EMO binding,
encoding related γ power during a verbal memory task, verbal memory, gender and serum acetylcholine level
will be explored. This exploratory study will provide the necessary pilot data to conduct a larger study to fully
investigate the heterogeneity of SZ with respect to M1 receptor availability.

Public health relevance
PROJECT NARRATIVE Cognitive deficits in schizophrenia (SZ) are a major cause of morbidity in the disorder; unfortunately, none of the currently available treatments adequately address cognitive deficits. Converging lines of research from post-mortem autoradiography, immunohistochemistry, and gene expression studies provide strong evidence that brain muscarinic M1 receptor availability and M1 mRNA expression is decreased in a subset of patients with SZ. This exploratory study will, for the first time, examine in vivo brain muscarinic M1 receptor availability in schizophrenia using a novel positron emission tomography (PET) ligand, [11C]EMO, and elucidate its relationship to cognitive deficits in SZ.